Oligodendrocyte-focused rAAV gene therapy strategies for Canavan disease and Leukodystrophies

PROJECT SUMMARY
Zolgensma, an FDA-approved gene therapy, employs recombinant adeno-associated virus (rAAV) to treat
spinal muscular atrophy (SMA). However, toxicity and even death have been reported in patients, potentially
due to widespread transgene expression caused by a constitutively active and ubiquitous promoter.
Consequently, we have developed a second-generation therapy employing a cell type-specific promoter to
enhance efficacy while mitigating toxicity.
Similarly, Canavan disease (CD), a leukodystrophy linked to the aspartoacylase (ASPA) gene, is targeted with
rAAV-based gene therapy using a constitutively active and ubiquitous promoter, which has generated off-target
effects in mouse and human. To bolster safety and efficacy, we have devised a novel ASPA promoter derived
from the endogenous ASPA regulatory elements to emulate endogenous ASPA expression. In addition,
understanding the regulation of the ASPA promoter aims at further improving specificity and therapeutic
efficacy of the novel ASPA promoter (Aim 2).
While rAAV's efficacy in transducing neurons is well-documented—beneficial for disorders like SMA—the
understanding of rAAV's transduction of oligodendrocytes, the target cells in CD, is sparse. These cells play
pivotal roles in neurodegenerative diseases such as Leukodystrophies, multiple sclerosis, and Alzheimer’s;
hence, understanding their transduction by rAAV is crucial and has the potential to benefit diseases with
oligodendrocyte involvement. Furthermore, understanding the mechanism of AAV capsid-oligodendrocyte
interaction could inform novel capsid design for oligodendrocyte targeting and, together with a transgene-
specific promoter, improve specificity and safety of oligodendrocyte-targeted rAAV gene therapy for CD (Aim
1).
In conclusion, the urgent need to comprehend oligodendrocyte transduction, along with the promising
advancements in gene therapy, emphasizes the significance of our study. The outcomes will enhance
treatment safety and efficacy and broaden the application of gene therapy to oligodendrocyte diseases
currently considered challenging to treat.

Public health relevance
PROJECT NARRATIVE To target oligodendrocyte-centered diseases more effectively, it is imperative to understand the mechanisms that govern the specificity (capsid, promoter) of oligodendrocyte transduction by recombinant adeno- associated virus (rAAV). Yet, our grasp on what controls transduction in general, and specifically across the oligodendrocyte lineage by rAAV, is currently inadequate. This proposal scrutinizes pivotal elements in oligodendrocyte-capsid interaction and the strategic choices in vector design that regulate oligodendrocyte transduction by rAAV. A severe pediatric neurodegenerative disease serves as our model system in this endeavor as we examine the potential of disease-specific promoter usage to increase specificity, thereby heightening safety.